Immunology and Pathogenesis Program Training Grant

This competing application for a training program in Immunology and Pathogenesis (IMP)
supports the training activities of 15 field-leading scientists whose research centers on
immunobiology. The training faculty are all members of the Department of Molecular and Cell
Biology (MCB), and each has ample research support and a strong commitment to mentoring.
The training program is centered in the MCB Division of Immunology and Pathogenesis, in
which most training faculty are members. The IMP Training program focuses on basic
immunological mechanisms in the context of infections, cancer and immunopathology. We are
motivated by the shared belief that achieving a thorough, basic understanding of
recognition, activation, regulation, differentiation and interactions of cells of the immune
system will lead to therapies for infectious disease, cancer and other ailments, and that
training young investigators in this approach, while providing broad training in basic
molecular and cell biology, offers a most productive avenue for enhancing success in
this endeavor. The program is strongly committed to recruiting and training students and
postdocs from diverse personal backgrounds. The IMP training program will provide a home for
trainees in Immunology and Pathogenesis and support for training related activities. We
propose support for 4 graduate students and 3 postdoctoral fellows. Graduate students will
generally be supported starting in their second year to ensure commitment to the research area
and to provide additional information to evaluate their capability of providing exceptional
contributions to the program. Postdoctoral trainees will generally be supported starting in their
first or second year. In general trainees will be supported for 2 years on the training grant, with
additional years supported from other sources. While this training grant is currently in its 5th
year, the grant is the successor of an NCI-supported training grant (Molecular Immunology and
Tumor Biology Training Program, T32 CA009179), which supported immunology research at
Berkeley for 35 years.

Public health relevance
Project Narrative The relevance of immunology research to advances in public health has never before been so strong. This pre- and post-doctoral training program is committed to inculcating detailed understanding of the immune system as well as broad knowledge of molecular and cell biology and the principles of rigorous, elegant experimentation, in a manner that fosters innovative and inspirational contributions by the next generation of immuno-biologists. !